Autophagic Regulation of Eye Interaction

Herpes simplex virus type-1 (HSV-1) provides a valuable tool for identifying new cellular
mechanisms that safeguard the cornea and innervating sensory nerves. HSV-1 infections in
the cornea can lead to epithelial damage, chronic inﬂammation, and impairment of
sensory nerve ﬁbers, ultimately resulting in blindness. In recent research, we investigated
the role of the optineurin (OPTN) gene in HSV-1 infection and unexpectedly found an
inverse correlation between OPTN expression and the severity of herpes stromal keratitis
(HSK) in experimental mice. Our published ﬁndings also demonstrated that OPTN
dysfunction leads to accelerated loss of central nervous system (CNS) neurons after HSV-1
eye infection. OPTN-/- animals show issues with the development of adaptive immune
responses and deﬁciencies in autophagic degradation of HSV-1 proteins. Notably, OPTN,
an autophagy receptor, is known for regulating the transport of ubiquitinated proteins and
damaged mitochondria to autophagosomes for degradation. Our preliminary ﬁndings using
OPTN-/- animals indicate that the loss of OPTN directly correlates with the loss of corneal
nerve functions, including mitochondrial dysfunction, underscoring its unrecognized
signiﬁcance in herpes neurotrophic keratitis (HNK) and other sensory nerve complications,
such as dry eye disease (DED). Based on our recently published and preliminary data, we
propose a stimulating hypothesis that OPTN plays a central yet poorly understood role in
mitigating the severity of herpetic eye disease. To deepen our understanding, we plan to
comprehensively investigate the impact of OPTN on herpetic disease in the cornea.

Public health relevance
Our research aims to uncover how mitochondrial dysfunction due to lack of cellular protein, OPTN, contributes to vision loss. This equipment will be used for measuring real- time cellular metabolism to drive these discoveries and identify new treatment strategies. .